ISV - International Society for Vaccines 2024 Annual Congress

Project Summary / Abstract
The International Society for Vaccines (ISV) is a not-for-profit membership organization founded in
1992 with members and delegates from 47 countries, holding annual congresses since 2007. The ISV
Annual Congress is the world’s largest non-commercial scientific conference for researchers
interested in vaccines and immunotherapeutics and the underlying sciences. The topics include
prophylactic and therapeutic vaccines of infectious and chronic diseases and cancer, and human and
animal vaccines, including the intersection of One Health. Presentations cover basic research
through manufacturing and clinical trials.
ISV intentionally rotates the sites of the meetings between Asia, North America, and Europe, in
accessible locations for strong regional and international representation. ISV attracts renowned
leaders in vaccine fields while simultaneously providing opportunities for scientists from low- and
middle-income countries (LMICs) to attend both virtually and in person, and for students and early
career researchers (ECRs) to present and gain personalized feedback and mentoring by senior
scientists. ISV is particularly committed to ensuring participation of female, underrepresented, and
junior investigators.
The 2024 ISV Annual Congress, to be held in Seoul, South Korea, aims to highlight the very latest
ground-breaking developments in vaccine research, manufacturing, clinical development and
implementation, and safety. Plenary and parallel sessions are devoted to current hot topics spanning
diverse areas of vaccinology. Poster sessions will allow more free and diverse scientific exchange of
early research findings. Funding from NIAID R13 conference grant mechanism will provide critical
support to LMIC delegates and students in vaccinology.

Public health relevance
Project Narrative In an academic, non-commercial setting, the ISV Annual Congress uniquely brings together vaccine scientists from all sectors of basic research through clinical development, focused on technologies, best practices, policies, safety, and immunological challenges of different populations to target acute and chronic diseases in humans and animals. The ISV Annual Congress was held mainly in the US but also rotated among other continents to reach a global vaccine community. The 2024 ISV Annual Congress will be held in South Korea in collaboration with International Vaccine Institute (IVI) affiliated with the United Nations Development Programme (UNDP). The program will focus on the very latest epidemiological, scientific, and technological developments related to vaccines, while also providing crucial updates on fundamental scientific advances. ISV is devoted to its global membership, alternating Congress locations to bring together local, regional, and international researchers for fruitful exchange of information with simultaneous virtual offerings for persons unable to physically attend yet also interested in accessing the science and connecting with other scientists.